Therapeutic Targeting of Casein Kinase-1-delta in Primary and Metastatic Breast Cancer

Project Summary Our Multi-PI research team recently reported that the delta isoform of casein kinase-1 (CK1δ) is amplified and/or overexpressed in over a third of all breast cancers, and that CK1δ activation is especially manifest in refractory forms of breast cancer such as triple-negative breast cancer (TNBC) that lacks targeted therapies. Further, we established that silencing CK1δ, or inhibition of CK1δ kinase activity with our nanomolar potent, highly selective small molecule dual inhibitor of CK1δ and CK1ε, specifically compromises the growth, survival and invasion of breast cancer cells that overexpress CK1δ. Notably, CK1δ inhibition also provokes tumor regression of TNBC, including lung metastatic TNBC and basal-like PDX breast cancer models, and without any overt side effects. Finally, we demonstrated that CK1δ inhibition disables WNT/β-catenin signaling, a frequently activated yet heretofore undruggable pathway that is activated in a broad cast of human malignancies. Importantly, our new studies suggest roles for CK1δ in TNBC metastasis, where we have now shown that CK1δ signaling is necessary to sustain the expression of: (i) transcription factors that direct the epithelial to mesenchymal transition (EMT), including Zeb1 and Snail2; (ii) matrix metalloproteinases-1 (MMP1), MMP2 and MMP9 that control TNBC cell invasion; and (iii) the breast cancer stem cell (BCSC) factors Bmi1 and Sox9 that control self renewal. Finally, we have shown that our CK1δ inhibitors have synergy with select in-clinic DNA-damaging chemotherapies used to treat TNBC. Collectively, these data support the hypotheses that CK1δ is a driver of breast cancer metastases and that targeting CK1δ will block and improve treatment of metastatic triple negative breast cancer. Accordingly, in Aim1 we will use an iterative and rigorous research operating plan (ROP) to improve the pharmacokinetic (PK) properties of our dual CK1δ/CK1ε inhibitors, and will develop and test the efficacy of CK1δ-selective inhibitors, to deliver safety assessment candidates suitable for subsequent IND-enabling studies. This ROP includes tests of synergy of our inhibitors with in-clinic agents used to treat TNBC. Further, using genetic approaches and our CK1δ inhibitors, in Aim 2 we will test roles for CK1δ in each step of the metastatic cascade, including intravasation, extravasation, latency and/or establishment at the secondary site. Finally, in Aim 3, using phosphoproteomics, activity-based proteomic profiling, and RNA-seq we will identify and test the roles of downstream effectors of CK1δ in controlling TNBC metastasis, and the EMT, MMPs and BCSC targets of CK1δ signaling. These studies, and those in TNBC that we have generated that are resistant to our CK1δ/ε inhibitors, will define acute and chronic changes in components of the kinome that could be exploited for combination studies, to improve therapeutic response and block the emergence of resistance. We submit our research program will establish CK1δ as a vulnerability to target metastatic triple negative breast cancer, and that the small molecule CK1δ/ε or CK1δ inhibitors that we develop will have a major impact in the breast oncology clinic. !

Public health relevance
Program Narrative Most triple negative breast cancer (TNBC) patients initially respond to treatment, yet disease frequently recurs and is associated with metastasis and the acquisition of a chemoresistant phenotype that prevents successful treatment. New findings of our Multi-PI research team have shown that: (i) the serine/threonine kinase CK1δ is amplified and/or overexpressed in TNBC; (ii) silencing CK1δ, or treatment with our in-house, potent, and highly selective small molecule CK1δ inhibitors, compromises TNBC cell growth, survival, and invasion, provokes TNBC tumor regression and greatly impairs metastasis; and (iii) CK1δ is necessary to sustain the expression of key targets that control the epithelial-to-mesenchymal transition, breast cancer stem cell self renewal and cell invasion. Accordingly, using a battery of approaches, we will: (a) optimize CK1δ inhibitors to deliver a safety assessment candidate that is suitable for TNBC clinical trials; (b) define the specific roles that CK1δ plays at each step of the metastatic cascade; and (c) identify and test the roles of downstream effectors of CK1δ in controlling TNBC metastasis, as well as effectors that mediate resistance to our CK1δ inhibitors, to define optimal drug combinations and devise strategies to overcome resistance mechanisms. !